KETOACID EFFECTS ON AMINO ACID METABOLISM IN INSULIN DEPENDENT DIABETES MELLITUS

Use of low-protein diets and exogenously administered ketoanalogues of essential amino acids to probe amino acid metabolism in insulin dependent diabetes mellitus.